Administrative Core

Project Summary/Abstract – Administrative Core
The Administrative Core of the Fred Hutch Lung SPORE will provide the necessary infrastructure, organization,
coordination, and fiscal management necessary to successfully complete the tasks proposed within this
application. Ultimately, the responsibility for the successful completion of all SPORE related activities belongs to
Dr. Houghton, the SPORE PI. The Lung SPORE Administrator, Jessica Paulishen, will carry out all administrative
responsibilities. Collectively, the Fred Hutch Lung SPORE Leadership and Executive Committee will coordinate
all SPORE related activities. Advice received from advisory boards will be implemented into the program through
the administrative core. Specific tasks of the Administrative Core will include: 1) to provide coordination and
oversight to all Lung SPORE activities to meet the scientific and administrative needs of the individual projects
and cores, 2) to provide fiscal management of grant funds for projects and cores, 3) to prepare and file regulatory
documents and progress reports, 4) to administer the Developmental Research Program and Career
Enhancement Program, 5) to coordinate SPORE interaction with the Fred Hutch/UW Cancer Consortium, 6) to
arranged the monthly Lung SPORE Research Meeting and the annual Lung SPORE Retreat, and 7) to provide
oversight for all necessary regulatory requirements and documentation.